Cell-type-specific molecular pathology of ALS in U.S. military Veterans

Amyotrophic lateral sclerosis (ALS) is a devastating human neurodegenerative disorder that is
manifested in the degeneration of upper and lower motor neurons. ALS has higher incidence in U.S. military
Veterans than in the general population and is considered a service-connected condition. Understanding the
biological basis of ALS remains a major challenge, which is largely due to the complexity of the human central
nervous system, which contain vast numbers of specialized cell types. Whereas the original focus of ALS
research was concentrated on motor neurons, the non-neuronal cell types have also been suggested to play a
crucial role in motor neuron death. Previous studies used genome-wide analysis of gene expression in bulk
brain tissues to assess transcriptional changes associated with ALS. However, information on key changes that
could affect different cell types in ALS brain remains limited. One reason is that changes affecting a particular
cell type cannot be reliably inferred from data on bulk brain specimens that conflate signals from all cell types.
The majority of ALS cases (~90%) occur sporadically (sALS) with unknown etiology, while ~10% of cases
are classified as familial (fALS). To date, mutations in more than 50 genes have been linked to fALS. Expansion
of the hexanucleotide repeat in C9orf72 (C9) gene is the most common cause of ALS and another
neurodegenerative disorder, frontotemporal dementia (FTD), accounting for ~ 11% of all ALS and ~13% of all
FTD cases. We recently performed single nucleus (sn)RNA-seq analysis using autopsied motor and prefrontal
cortices from ALS and FTD cases with a C9 mutation and from controls. We identified disease-related changes
in many cell types, including shared effects in ALS and FTD, and numerous disease-specific alterations. Among
other findings, we detected changes in gene expression in endothelial cells, astrocytes, and excitatory neurons
from C9-ALS cases that suggest a specific intercellular pathway that might, at least in part, underlie an ALS-
associated glutamate (Glu) excitotoxicity. Our application aims to address the following issues: (1) Our snRNA-
seq studies were limited to C9 cases; therefore, it is not known if the observed cell-type-dependent deficits are
specific for C9-ALS or are also present in patients with sALS. (2) Although ALS typically leads to death within 3
to 5 years after initial symptom onset, approximately 10% of patients with ALS live significantly longer (>10 years
after symptom onset; hereafter named “long duration ALS”) [10]. The molecular underpinnings of these
differences have not been investigated. To address these issues, we propose the following Aims:
Aim 1: To study cell-type-specific transcriptional dysregulation in the brains of U.S. military Veterans
with sALS in single cell resolution. Hypothesis: Transcriptional deficits that we identified in C9-ALS patients
and which, at least in part, explain the ALS-associated Glu excitotoxicity, are also present in the brain of military
Veterans with sALS. We will test this hypothesis by performing snRNA-seq in the brains of standard duration
sALS cases and controls (Ns=24) from the Department of Veterans Affairs Biorepository Brain Bank (VABBB).
Aim 2: To elucidate cell-type-specific underpinnings of the long duration sALS phenotype. Hypothesis:
Compared with standard duration sALS, long duration sALS is characterized by both unique and overlapping
neurotoxic pathways. We will test this hypothesis by performing snRNA-seq in long duration sALS cases from
VBBB (N=24) and comparing transcriptomes between standard (Aim1) and long duration sALS.
Aim 3: To validate sALS-associated deficits in major cortical cell types. 3a. We will employ our novel
nuclear sorting protocol to isolate nuclei from four major brain cell types (neurons, oligodendrocytes, astrocytes,
and microglia) from the sister aliquots of samples used in Aims 1-2. We will use these preparations to validate
the most significant snRNA-seq findings by qPCR. 3b. RNA-seq studies do not inform if the identified gene
expression changes translate into changes in proteins. Here we will use immunostaining to investigate proteins
encoded by sALS-associated genes from Aims1-2 that will have been validated in Aim3a.

Public health relevance
Amyotrophic lateral sclerosis (ALS) is a deadly neurodegenerative disease with higher incidence in U.S. Veterans and is considered to be a service-connected condition. Understanding the biological basis of ALS remains a major challenge. Whereas the original focus of ALS research was concentrated on the degenerating motor neurons, distinct yet overlapping pathology in different cells types have been reported in ALS patients. The proposed research will use state-of–the-art approaches to study ALS in different brain cell types from the autopsied brains of U.S. Veterans.